Molecular mechanisms that regulate ADAR target recognition and RNA editing in vivo

Project Summary
Sequence alterations that change the genome-encoded information present in RNAs, referred to as RNA
editing, provide a powerful way to diversify the transcripts expressed in an organism’s tissues over time. The
objective of the parent research proposal is to determine molecular mechanisms of how RNA binding proteins
influence substrate recognition by the ADAR RNA editing enzymes. ADARs catalyze millions of adenosine (A)
to inosine (I) modifications in eukaryotic transcriptomes to play an essential role in the creation of proteomic
and phenotypic diversity. Despite the prevalence of A-to-I editing, there is a gap in knowledge of how ADARs
edit specific adenosines to varying degrees during development and in specific cell types. My lab has made
significant contributions to this outstanding question by identifying roles for naturally occurring editing-deficient
ADAR proteins in regulating editing. The proposed research takes an integrated approach using both the
model organism, Caenorhabditis elegans, and human glioblastoma (brain tumor) cell lines with a combination
of biochemistry, genomics, and molecular biology to connect the molecular mechanisms of RNA recognition by
ADARs to functional consequences on RNA editing and gene expression. Our main goals are to define the
molecular mechanism of how an editing-deficient ADAR protein can recruit the RNA editing enzyme to specific
adenosines in vivo, dissect the mechanism of how certain neural transcripts are selectively edited and to
determine the cellular targets and impact of the editing-deficient human ortholog on the glioblastoma
transcriptome.
Over the last year, we have made exceptional progress on understanding the in vivo RNA binding sites
of C. elegans ADR-1 (the deaminase-deficient ADAR) and ADR-2 (the editing enzyme). In this supplemental
proposal, I am requesting funds to support the salary and training of a post-baccalaureate student that is from
an ethnic group that is underrepresented in health-related sciences within the United States. This individual will
perform experiments related to goals of the parent grant while also receiving direct mentoring in academic
research and core professional skills, which will enable her to be competitive to enter graduate training wherein
she will help to increase the Hispanic physician scientist population, which currently only make up 5.8%
M.D./Ph.D. graduates in the US. The post-baccalaureate researcher will specifically work on three different
aims building from our recent preliminary data. She will 1) confirm novel RNA binding targets of ADR-1 and
ADR-2 using RNA immunoprecipitation coupled to quantitative real-time PCR (RIP-qPCR), 2) examine the
impact of ADR-1 binding on gene expression using qPCR and 3) design in vivo reporter models to examine
how loss of ADR-1 binding sites influences editing. Completion of any one of the goals over the next year will
further our understanding of the role of non-editing ADAR family proteins in gene regulation, results of which
will be shared in research conferences and publications.

Public health relevance
Project Narrative The proposed studies in the parent grant are designed to determine the molecular mechanisms that regulate editing of specific adenosines within RNA molecules in vivo. As alterations in RNA editing occur in over 35 human pathologies, the fundamental knowledge from our studies represents a critical first step in developing therapeutics that modulate editing and improve human health. In this supplemental proposal, I am requesting funds to support the salary of a historically marginalized, post-baccalaureate student that will perform experiments related to goals of the parent grant while also receiving direct mentoring in academic research and core professional skills.